TCR-dependent activation, functional differentiation and memory formation of CD4+ T cells following infection

Project Summary
Because of their elevated frequency, ability to self-renew and rapid acquisition of effector function
following re-activation, memory T cells have an enhanced ability to protect from secondary challenge. The
generation of memory T cells is the focal point of numerous vaccine and immunotherapeutic strategies. Most
(90-95%) effector T cells die after pathogen clearance, but those fated to become memory cells can be
identified during the primary effector response, showing that activated T cells receive differentiation cues
during the primary response to infection that influence memory fate differentiation. We have recently shown
that T cell receptor (TCR) signals play a key role in driving CD4+ memory T cell differentiation. TCRs that are
able to engage MHC Class II-bound antigen (pMHCII) in sustained interactions are biased towards the
formation of long-lived memory, while TCRs that engage in short-lived interactions with antigen are biased
towards terminal effector cell differentiation. We will build on those studies by using diverse infectious models
to define aspects of the TCR-dependent activation and transcriptional program that leads to the formation of
lymphoid-resident, circulating and tissue-resident CD4+ memory T cells. We pose three key questions. First,
what is the role of TCR signal strength in the formation of memory T cells? We will explore the hypothesis that
increasing TCR signal strength in vivo drives terminal effector T cell differentiation, while weaker TCR signal
strength allows memory T cell formation. Second, what are the TCR binding parameters associated with
memory T cell development? We will measure 2D affinity and bond lifetime with the application of force for
TCRs at that are effector-biased or memory-biased. We will test the hypothesis that bond lifetimes will predict
TCR-dependent memory differentiation. Third, what are the transcriptional programs that control memory
formation? We will test the mechanistic role of molecules that are differentially expressed in memory T cell
precursors during the primary effector response, including TCF-1. We anticipate that resolution of the
questions posed in this study will provide a framework for determining in greater mechanistic detail how
memory T cells form and identify therapeutic approaches for directly modulating CD4+ effector and memory T
cell differentiation in vivo.

Public health relevance
Project Narrative The development of immunological memory is a fundamental component of the immune system's ability to provide protection from previously encountered infectious pathogens. This project will determine how T cells, the central component of immunological memory, acquire the characteristics of memory that allow them to provide robust immune protection. Understanding these requirements is a pre-requisite to the design of more effective vaccination and immunotherapeutic strategies aimed at inducing protective immunity, with particular relevance to infectious diseases and cancer.